Enhancing FAIRness of the FaceBase Research Data Hub

PROJECT SUMMARY The goal of the FaceBase III Hub is to create a data repository to serve the entire community of dental and craniofacial researchers by sharing diverse data related to craniofacial development and dysmorphia, as well as other research communities that can leverage the diverse data that is in the FaceBase repository. FaceBase was designed to follow FAIR data principles: that data be Findable, Accessible, Interoperable, and Reusable. To date, we have had significant success getting new research teams to submit data to FaceBase in a manner that adheres to FAIR. However, since the start of FaceBase III, the digital repository community has developed a new set of principles designed to promote trust in the data contained in a repository with the goal of promoting broader reuse of the data within the repository. The TRUST principles of Transparency, Responsibility. User Focus, Sustainability, and Technology have been identified as core to increasing users’ confidence in a data-repository and hence promoting data use and reuse. Surveys and interviews of FaceBase users indicate that FaceBase is perceived within the community as being a high-quality trustworthy repository. However, a deliberate application of TRUST guidelines has the advantage of making FaceBase commitment to these principles more explicit, increasing our ability to promote the use of FaceBase data outside of the core craniofacial research community, and better serving our users across the NIH research community. In this proposal, we seek to achieve these goals by explicitly identifying, defining, and adopting operational principles in FaceBase to meet community agreed-upon standards for TRUST (Aim 1). A critical part of TRUST is to define specific metrics that enable one to evaluate the impact of the data repository. To this end, we will leverage the extensive built-in analytics that FaceBase collects to define key performance metrics of impact and produce a reporting structure to disseminate those metrics to the FaceBase user community (Aim 2). Ultimately, the goal is for the FaceBase Hub to become a certified trusted data repository. Certification will establish greater credibility for the FaceBase Hub with our user community and with users less familiar with FaceBase. Long term, the adoption of TRUST principles will ensure that datasets deposited with us and entrusted to our care will be maintained at the highest level of quality.

Public health relevance
PROJECT NARRATIVE Craniofacial dysmorphia is one of the leading causes of birth defects, and in recognition, the major goal of the FaceBase III project is to advance research by creating comprehensive datasets of craniofacial development and dysmorphologies and to disseminate these datasets to the wider research NIH research community. By design, FaceBase is constructed so that its data be FAIR: Findable, Accessible, Interoperable, and Reusable. However, as the size and scope of FaceBase data grow, the impact of the resource can be enhanced both within the Craniofacial research community and in other communities that can leverage FaceBase data if the repository also followed the more recently identified principles of Transparency, Responsibility, User-focus, Sustainability, and Technology, or TRUST. While FaceBase already complies with some elements of TRUST, there are gaps that would prevent FaceBase from receiving TRUST certification. The goal of this project is to evolve FaceBase in such a way that TRUST certification can be obtained, with the goal of expanding the usefulness of FaceBase for the NIH research community.